Genetic Silencing of Striatal CaV1.3 Calcium Channels as a Potent Antidyskinetic Therapy for PD

Project Summary
The often debilitating side-effect of standard pharmacotherapy for Parkinson disease (PD), levodopa-induced
dyskinesia (LID) continues to be a serious complication of medical treatment for individuals with PD. Despite
eventually occurring in greater than 90% of individuals, there is the only one FDA-approved drug for LID.
However, it is only partially effective, works best in cases of mild LID, and can itself produce significant adverse
events. Maintaining the motor benefits of PD therapies while avoiding LID remains a significant unmet clinical
need. Our research program has been validating striatal voltage gated CaV1.3 calcium channels as a
therapeutic target for LID amelioration. Our initial proof-of-principle data demonstrated that reducing striatal
CaV1.3 expression with adeno-associated virus (rAAV) CaV1.3 short-hairpin (sh)RNA expression in YOUNG
(2mo) MALE parkinsonian rats provided near complete, uniform protection against LID induction, and provided
significant (60%) reversal of already established severe LID. Importantly this approach did NOT interfere with,
and in fact appeared to enhance, motor activation of levodopa. As age is the greatest risk factor for PD and
that there are sex-related differences in both PD and LID, in the first iteration of this R01 we expanded our
target validation studies into older male and female parkinsonian rats and nonhuman primates (NHPs). For
these studies, we principally employed the proactive approach of preventing LID induction, reasoning that if
aging precluded, or significantly diminished the ability of this molecular therapy to ameliorate LID severity, a
proactive paradigm was the most reasonable initial approach. Using a mix of proactive (rat & NHP) and
reversibility paradigms (rat only), our studies performed during the first iteration of this award continue to
robustly support the concept that striatal CaV1.3 silencing is a potent therapeutic for preventing LID induction
(rats & NHPs) and escalation of pre-existing mild LID (rats) in aging parkinsonian subjects of both sexes.
However, these studies provide crucial scientific insight that advancing age, female sex, and introducing
CaV1.3 silencing after LID induction in older parkinsonian rats (15-18 mos) increased variability and
decreased overall benefit of therapeutic response. In contrast, in aged parkinsonian NHPs (24-29 yo)
proactive intervention with AAV-CaV1.3-shRNA provided profound antidyskinetic benefit and significant
diminution of long-standing severe parkinsonian disability, ‘ON’ and ‘OFF’ levodopa, in both male and female
aged macaques. We posit the next logical steps for this research program, aimed at understanding the
potential clinical application of this gene therapy in PD, is to define the therapeutic benefit (i.e., reversal of LID
and parkinsonian disability) once LID have been induced using the gold standard preclinical parkinsonian NHP
model. We propose here a series of studies directed at determining the capacity and/or limitations of reversing
established LID and long-standing parkinsonian disability, modeling therapeutic efficacy of CaV1.3 silencing in
two demographics of PD, specifically in those with idiopathic PD and those with young onset PD (YOPD).

Public health relevance
Project Narrative (3 sentences) Striatal calcium voltage-gated (CaV)1.3 channels represent a novel molecular target for levodopa-induced dyskinesias (LID), which remains a serious complication to medical treatment of individuals with Parkinson disease (PD). Acknowledging that age is the greatest risk factor for PD and that there are sex-related differences in PD and LID, in the previous iteration of this R01 award we expanded our research program, aimed at validating this promising target, into male and female parkinsonian rats and nonhuman primates (NHPs) of advancing age demonstrating for the first time that when gene-therapy mediated CaV1.3 silencing is employed as a proactive precision therapy in the aging brain there is maintenance of a profound antidyskinetic benefit and a striking reversal of long-standing parkinsonian disability, particularly pronounced in aged NHPs. In this competitive renewal, we propose a set of studies directed at determining the capacity and/or limitations of reversing established LID, modeling exploration of the therapeutic efficacy of CaV1.3 silencing in two demographics of PD, specifically in those with idiopathic PD and those with young onset PD (YOPD).